ADMINISTRATION

PROJECT SUMMARY/ABSTRACT
The Administrative Office of the Tisch Cancer Institute (TCI) provides dedicated and effective administrative
support to the Center Director, Deputy Director, Associate Directors, Program Leaders and Shared
Resources Leaders. The overall goal is to facilitate collaborative and innovative cancer research through
strong operational and financial management of TCI resources. Operational management includes providing
support for processes related to decision-making, shared resources, membership, pilot awards, space
assignment and faculty recruitment/retention. Financial management includes oversight of all cancer center
funds including the CCSG grant, gift accounts, faculty start up packages, institutional budgets, shared
resource chargebacks and cancer clinical trial accounts. Tisch Cancer Institute administration is widely
recognized as an established and independent entity within Mount Sinai, equal to that of a department, and
works closely with the offices within the Icahn School of Medicine at Mount Sinai (ISMMS) and Mount Sinai
Health System, including Administration, Finance, Grants and Contracts Office, Business Planning, Human
Resources, Information Technology and Development to facilitate the vision and goals of the cancer center.